Overcoming Resistance to Targeted Therapy in Breast Cancer

PROJECT SUMMARY
Therapies directed against lineage and oncoprotein drivers in breast cancer have led to major improvements in
clinical outcomes, establishing the significance of these drug targets. In metastatic breast cancer, eventual
resistance to these drugs is unfortunately common and represents a major clinical dilemma. We have focused
our research efforts on understanding resistance to therapies against the major targets in luminal breast cancer
including ER, HER2, PI3K, and CDK4/6. Using a combination of clinic-genomic analyses, advanced breast
cancer modeling, and pharmacology, we have identified and characterized common resistance mechanisms
such as ESR1 mutations driving endocrine resistance, PTEN loss promoting insensitivity to PI3Ki, and HIPPO
pathway alterations and TP53 loss promoting CDK4/6i resistance. Even as these studies have paved the way
towards new biomarkers such as ESR1 ctDNA as well as new therapies such as oral SERDs, they have pointed
to a deeper challenge of breast cancer plasticity that underlies these acquired genetic alterations. So, despite
patients being treated with 2nd generation inhibitors or combinations, we are observing new forms of resistance
emerge. However, not all cases of metastatic breast cancer harbor this level of plasticity and there now also
exists a growing cohort of patients with long-term disease control that must be understood in comparison. In this
next phase of research into therapy resistance, we aim to elucidate the processes underlying plasticity and the
resulting therapy resistance centering on three broad questions. First, by what mechanisms do discrete forms of
genomic instability such as homologous recombination deficiency or APOBEC3 mutagenesis contribute to
therapy resistance. Second, by what effector pathways and mechanisms of cancer cell elimination do we observe
durable, long-term response to targeted therapies in subsets of metastatic breast cancer. Third, through which
aspects of the antibody-linker-payload construct of Antibody Drug Conjugates do breast cancers develop
resistance. The overall goal of this project is to establish the underlying mechanisms of response and resistance
to modern targeted therapy in breast cancer and use these insights to develop curative approaches for increasing
segments of this common disease.

Public health relevance
PROJECT NARRATIVE Metastatic breast cancer is one of the leading causes of death among women in the United States with mortality linked to the disease becoming resistant to lineage and oncoprotein targeted therapies. This project will determine the mechanisms of resistance to the most commonly used therapies in breast oncology practice using cohorts of patient samples and patient derived models, investigate the underlying processes that give rise to these mechanisms of resistance, and develop new pharmacologic approaches to suppress the emergence of resistance.